IMPACT OF A RANDOMIZED CLINICAL TRIAL EXAMINING THE PRENATAL PEDIATRICS VISITS

This study evaluates the impact of prenatal pediatric visits for new mothers. Outcome variables include rates of breastfeeding, infant car seat use, health care utilization and doctor-patient relationship.